Neurogenetic approaches to study directed behavior in Drosophila

PROJECT SUMMARY
Temperature sensing is an important constituent of the somatosensory system and arguably one of the most
ancient sensory modalities. Little is known about the central mechanisms that allow us to distinguish hot, cold,
and noxious temperatures, or on how different thermal ranges become innately associated with either
positive(“warm/cool”) or negative (“hot/cold”) hedonic valence in the brain. Our laboratory is addressing these
fundamental questions by studying the circuit mechanisms underlying temperature sensing and preference in
the fruit fly Drosophila. Supported by this grant, we have embarked in an effort to follow the full processing of
temperature information in the fly brain: from detection at the periphery to the initiation of directed behavioral
responses. This work has been uncovering, for the first time, the logic and mechanisms of thermosensory
processing in the fly brain. We expect our results will reveal conserved principles of central sensory processing
that have been difficult to uncover in more complex brains and will elucidate how sensory cues become
associated with innate preference to guide behavior.

Public health relevance
PROJECT NARRATIVE Our long-term goal is to understand how sensory stimuli are represented in the brain and integrated to produce directed behaviors. The studies outlined here will provide insight into the cellular and circuit logic for the processing if thermal stimuli in the fruit fly brain. Our expectation is that this work will reveal conserved principles of central somatosensory processing that have been difficult to uncover in more complex brains and will elucidate how sensory cues become associated with innate preference to guide behavior.